Buffalo Clinical and Translational Research Center

The Buffalo Translational Consortium (BTC), which includes the University at Buffalo (UB) health sciences
schools, the major healthcare institutions in our region, four key research institutes and five influential community
partners, have embarked on a comprehensive strategic plan to build a strong foundation for clinical and
translational research in response to our community needs. Buffalo is the second most populous city in New
York State and has a rich cultural history. The proportion of underrepresented minorities in Buffalo in 2018 (50%)
parallels that projected for the US in 2050, making Buffalo a microcosm of what the US will look like in 30 years.
A similar proportion of our population experiences health disparities. The vision for our CTSA hub is to perform
innovative research across the translational spectrum to improve the health of our community and the nation.
We will develop, test and share novel approaches to engage difficult-to-engage populations and reduce health
disparities in our community, which represents a “population of the future”. Guided by our vision, the CTSA has
catalyzed a transformation of our environment since our CTSA was first funded in August 2015 with remarkable
growth in clinical and translational research. Further, in just the past year, the UB medical school has moved into
a spectacular new building and our clinical partner, Kaleida Health, the largest healthcare system in the region,
opened the new Oishei Children’s Hospital, both on the Buffalo Niagara Medical Campus and connected to the
Clinical and Translational Research Center devoted entirely to clinical and translational research that opened in
2012. This rapid and continuing trajectory of growth in healthcare and research in the region has resulted in a
new 21st century Academic Health Center with healthcare, medical education and clinical and translational
research on one campus in the heart of Buffalo, creating a foundation to enhance the impact of our CTSA even
further. While launching our CTSA, we have prioritized participation in the national consortium through hosting
and testing Innovation Labs as a team science tool, working with multiple hubs on initiatives to solve translational
research barriers and sharing tools that we have developed with the CTSA consortium, including novel health
informatics tools. Our CTSA has five ambitious but achievable aims, including: 1) Accelerate innovative
translational research with teams that engage communities, regional stakeholders and the national consortium;
2) Train an excellent, diverse workforce to advance translation of discoveries; 3) Enhance inclusion of special
populations across the lifespan and difficult-to-engage populations; 4) Streamline clinical research processes
focusing on quality and efficiency with emphasis on multisite studies; 5) Develop, test and share biomedical
informatics tools to integrate data from multiple sources to speed translation. Guided by our vision to perform
research to improve the health of our community and the nation, we will continue our momentum to expand
translational research, train our diverse workforce, streamline processes, engage our community, and actively
contribute to the national consortium.

Public health relevance
The University at Buffalo Clinical and Translational Science Institute (CTSI) is the coordinating center of the Buffalo Translational Consortium, which includes the region’s premier research, educational and clinical institutions with influential community partners. The vision of the CTSI is to perform innovative clinical and translational research to reduce health disparities and improve the health of our community and the nation. We engage our community as research partners to create a shared environment to bring discoveries in the laboratory, clinic and community to benefit individual and public health.